The Role of FMN Loss by Mitochondrial Complex I in Neonatal Hypoxic-Ischemic Brain Injury

In the US, perinatal hypoxia-ischemia (HI) encephalopathy brain injury remains one of the major causes of
cerebral palsy and other life-long neurological disability. The life-time cost for patients with cerebral palsy is
estimated to reach 11.5 billion dollars. This dictates a need for therapeutic strategies based on better
understanding the mechanisms of hypoxic ischemic injury. HI-reperfusion-associated oxidative stress negatively affects glycolysis, the Krebs cycle, mitochondrial
energy metabolism, and causes abnormal permeability of the inner membrane and oxidative stress. These serve
as the major factors associated with brain tissue damage in HI. However, the exact mechanisms of the so-called
secondary energy failure in ischemia/reperfusion are not known. We propose that, brain oxygen deprivation
leads to conditions in which mitochondrial complex I loses its natural cofactor, flavin mononucleotide (FMN). Our
preliminary data identifies the mechanism of flavin loss by mitochondria and show that it is taking place in the
brain in vivo and can be prevented by the administration of FMN precursor, riboflavin and hypothermia. We pursue a novel hypothesis which is consistent with experimental data observed in HI and stroke models: increased ROS generation and mitochondrial bioenergetics failure. This project investigates preclinical
approaches to attenuate this damage by modulating FMN handling. The data obtained in this study will
significantly alter the current paradigm of the origin of neuronal ischemia/reperfusion damage. We aim to prove
the major role of FMN release from mitochondria in bioenergetics failure in stroke and HI. The preclinical impact
of this project is to provide a rationale for further clinical studies aimed at the reduction of post-HI brain injury.

Public health relevance
The worldwide mortality from perinatal hypoxic–ischemic (HI) injury reached 1.15 million in 2010. Perinatal HI brain injury also causes long-term neurological disability and morbidity in infants. Our project is focused on the novel, unexplored cause and mechanism of tissue damage in the brain after oxygen deprivation and proposed studies will unravel potential pharmacological targets for improving the outcome of ischemia/reperfusion and our results also help to establish a mechanistic basis of hypothermic neuroprotection in HI-reperfusion.